Mitochondrial respiratory uncoupling and the pathogenes*

Increased fuel delivery to mitochondria will generate substrate for mitochondrial respiration increasing the inner membrane potential (psidelta) thereby providing energy for ADP conversion to ATP. However, another consequence of increased psidelta is the generation of reactive oxygen leading to formation of superoxide and secondary generation of more detrimental free radicals. Hence, mitochondrial free radical formation may be one way in which increased fat delivery to non-adipose cells may be detrimental or induce "lipotoxicity". On the other hand, non-oxidative metabolism of excess fat may also lead to lipotoxicity through accumulation of cellular fat and induction of lipid peroxidation both of which may contribute to cell dysfunction or apoptosis. There is evidence that mitochondria may adapt to increased fuel delivery through increased respiratory uncoupling. In fact, various physiologic states associated with increased circulating free fatty acids (FFAs) result in enhanced mitochondrial expression of uncoupling proteins capable of dissipating mitochondrial potential (deltapsi) theoretically protecting against both respiratory generation of reactive oxygen species (ROS) and accumulation of intracellular fat through non-oxidative pathways. There is also evidence for interactions between ROS and nitric oxide (NO) production. Thus respiratory uncoupling through effects on ROS could later an important specialized function of endothelial cells, i.e. NO production. Given these considerations, this proposal will test the following hypotheses: 1. Although suggested by our preliminary data the actual role of UCPs in catalyzing the proton leak in endothelial cell mitochondria is not proven. We hypothesize that this is the case. Further, we hypothesize that superoxide enhances the proton leak in BAE cells. 2. Endothelial cells exposed to high fat feeding as opposed to high glucose content or usual nutrient conditions will accumulate intracellular fat and generate increased reactive oxygen. However, this will be associated with enhanced respiratory uncoupling. 3. Enhanced respiratory uncoupling protects against ROS and excess non-oxidative fat metabolism. This is mediated by one or more UCP subtype. 4. Altered mitochondrial coupling and consequent changes in mitochondrial ROS formation alter endothelial cell generation of nitric oxide.